PERIPHERAL CONTRIBUTIONS TO BLADDER HYPERSENSITIVITY

DESCRIPTION (provided by applicant): Disorders of urinary bladder sensation (discomfort, pain and increased sensitivity) characterize painful bladder syndrome/interstitial cystitis (PBS/IC). PBS/IC is a chronic and debilitating disorder in which urinary frequency and urgency are associated with small bladder volume. Pain, however, is the most common and most troubling symptom in PBS/IC patients and is typical of visceral pain in general - 94% of registrants in a PBS/IC database report pain referred to another pelvic area. Urodynamic studies in PBS/IC subjects confirm that bladder sensations and fullness are perceived at lower intravesical volumes, resulting in a leftward shift of the normal psychophysical function (i.e., bladder hypersensitivity). Because the visceral innervation is unique (organs are innervated by two nerves) and noxious visceral stimuli are unlike noxious tissue-damaging somatic stimuli, peripheral mechanisms of bladder hypersensitivity differ from those of somatic hyperalgesia. Mechanical and/or chemical hypersensitivity of the bladder largely underlies the pain and discomfort experienced by PBS/IC patients, yet the molecules and mediators that confer mechanosensitivity and/or sensitization of bladder sensory neurons and their contribution to urinary bladder pain are poorly understood. The ion channels TRPV1 and P2X3 have been implicated in bladder hypersensitivity. We hypothesize that TRPV1 and P2X3 contribute to mechanotransduction and/or sensitization of the bladder innervation and we will study their contributions: 1) using cystometry to functionally evaluate bladder hypersensitivity, 2) to mechano- and chemo-sensitivity of pelvic nerve and lumbar splanchnic nerve receptive endings in the bladder using an in vitro bladder-nerve preparation, and 3) to whole cell currents and excitability of bladder sensory neurons, identified by content of retrograde tracer.

Public health relevance
PUBLIC HEALTH RELEVANCE: Relevance: Interstitial cystitis (IC) is a chronic and debilitating disorder, most common in women, and in which pain is the most common and most troubling symptom. IC represents a hypersensitive condition and is difficult to manage. The objective of this research is to determine the mechanisms by which the pain in IC arises and is maintained as a first step in developing better informed and more successful management strategies. Relevance: Interstitial cystitis (IC) is a chronic and debilitating disorder, most common in women, and in which pain is the most common and most troubling symptom. IC represents a hypersensitive condition and is difficult to manage. The objective of this research is to determine the mechanisms by which the pain in IC arises and is maintained as a first step in developing better informed and more successful management strategies. __SpecificAimsTextDelimiter__ Specific Aims Disorders of urinary bladder sensation (discomfort, pain and increased sensitivity) characterize painful bladder syndrome/interstitial cystitis (PBS/IC). Inflammation is present in many, but not all major bladder disorders and non-ulcerative PBS/IC, for example, represents bladder hypersensitivity in the absence of apparent cause (i.e., there is no mechanical, biochemical or inflammatory condition to explain symptoms, the most common being pain). Visceral hypersensitivity thus often differs from somatic hyperalgesia, which is commonly associated with tissue injury and inflammation. Because the visceral innervation is unique (organs are innervated by two nerves) and noxious visceral stimuli (e.g., non-injurious distension/stretch) are unlike noxious tissue-damaging somatic stimuli, peripheral mechanisms of visceral hypersensitivity differ from those of somatic hyperalgesia and are poorly understood. Mechanical and/or chemical hypersensitivity of the bladder largely underlies the pain and discomfort experienced by patients with PBS/IC and other bladder disorders, yet the molecules and mediators that contribute to increased mechanosensitivity and sensitization of bladder sensory neurons are poorly understood. Peripheral terminals of sensory neurons innervating the bladder detect a variety of mechanical and chemical stimuli (e.g., distension/stretch, protons, ATP, etc.). Because intravesical local anesthesia, and in some cases capsaicin/resiniferatoxin or Botulinum toxin, can relieve bladder discomfort and pain in PBS/IC patients, we will continue to focus in this application on peripheral, afferent contributions to bladder hypersensitivity. To this end, we will employ: 1) cystometry to functionally evaluate bladder hypersensitivity (voiding and reflex micturition), 2) single fiber recording to examine mechano- and chemo-sensitivity of bladder afferent endings and 3) whole cell study of bladder sensory neuron currents (excitability) and agonist-produced inward currents. The latter two electrophysiological strategies will include investigation of both sources of sensory innervation of the bladder (the hypogastric/lumbar splanchnic and pelvic nerves) because we hypothesize that they play significantly different roles in bladder function and hypersensitivity. The ion channels TRPV1 and P2X3 have been implicated in bladder function and hypersensitivity. Based on the rationale developed in Significance, we will focus on the roles of TRPV1 and P2X3 in bladder hypersensitivity. The overarching hypothesis is that TRPV1 and P2X3 contribute to mechanotransduction and/or sensitization of the bladder innervation. We will take advantage of the availability of knockout mice to pursue the aims below, but as detailed in the application will also employ pharmacological strategies to verify the roles of TRPV1 and P2X3 in peripheral mechanisms of bladder hypersensitivity. The aims include: ¿ the first aim is to characterize the roles of TRPV1 and P2X3 in bladder function (by cystometry) in TRPV1, P2X3 and TRPV1-P2X3 knockout mice and wild type controls.1 Treatments include saline (vehicle control) and cyclophosphamide (cystitis) to produce a mild, non-ulcerative cystitis. ¿ the second aim is to characterize the roles of TRPV1 and P2X3 in mechano- and chemo-sensitivity of lumbar splanchnic and pelvic nerve afferent fibers that innervate the bladder. We will take advantage of the availability of TRPV1, P2X3 and TRPV1-P2X3 knockout mice to address this aim and - importantly - will incorporate appropriate pharmacological strategies to assess the roles of TRPV1 and P2X3. The innovative aspect of this aim is use of an in vitro bladder-nerve preparation in which receptive endings of different afferent classes in each innervation pathway (in different experiments) can be studied. An unbiased electrical search strategy will be employed to identify bladder receptive endings. ¿ the third aim is to study contributions of TRPV1 and P2X3 to bladder sensory neuron excitability using whole cell patch clamp methodology. Bladder neurons taken from TRPV1, P2X3 or TRPV1-P2X3 knockout and wild type mice treated with saline (vehicle control) or cyclophosphamide (cystitis) will be studied. The hypotheses and specific questions to be addressed in these aims are presented in Research Strategy. A strength of the proposed approach is the ability to couple functional (cystometry) evaluation of bladder hypersensitivity with electrophysiological analyses (via single fiber recordings and patch clamp study) of bladder sensory neurons. This research strategy is commonly employed in the laboratory and allows us to establish a mechanistic link to peripheral afferent mechanisms that underlie bladder hypersensitivity. 1 We have TRPV1 and P2X3 null mutant mice in hand and have bred them to produce a double TRPV1-P2X3 knockout (and various heterozygous combinations, which will be used as control subjects).